State Telehealth Policies and Mental Care for Children in Underserved Areas

PROJECT SUMMARY/ABSTRACT
Unmet need for child mental health services is a persistent and pressing public health problem in the US.
One of the key drivers of the unmet need is health workforce shortage, which has been exacerbated during the
COVID-19 pandemic. This exacerbation has occurred against the backdrop of rising mental disorders among
children, leading to the national emergency in child mental health declared by multiple specialty organizations.
At the same time, the pandemic has also stimulated innovations, including the widespread adoption of
telehealth, which has been promoted by recent government policies. Although telehealth has long been
advocated for improving health care access for vulnerable populations, such as children living in mental health
professional shortage areas (MHPSAs), no study to date has examined how the recent dramatic growth of
telehealth affects mental health care availability and utilization for children in MHPSAs. Furthermore, amid the
rapid transition to telehealth during the pandemic, some experts have been concerned with disparities in
telehealth access and utilization and called for further research on the equitable development of telehealth.
In response to that call, this proposed project aims to draw lessons about telehealth adoption during the
pandemic to inform future telehealth policies. As a comprehensive evaluation of state telehealth policies on
licensure, insurance coverage, and reimbursement, the proposed project has three aims: (1) mental health
treatment facility (MHTF) level analyses to assess how changes in state telehealth policies affect disparities in
mental health service availability for children from before to during the pandemic, (2) child level analyses to
evaluate how changes in state telehealth policies affect disparities in mental care access, utilization, and
spending among children from before to during the pandemic, and (3) qualitative interviews with medical
directors at MHTFs to understand their experiences using telehealth to serve children as well as facilitators and
barriers that they have identified for expanding telehealth in MHPSAs.
For each aim, we will analyze two types of disparities—by area of residence (e.g., MHPSAs vs. non-
shortage areas), and by child socio-demographic characteristic (e.g., race/ethnicity). Examining these
disparities is crucial given the concern about digital health equity during the pandemic.
To examine the aims, we will analyze quantitative data from both primary and secondary sources,
including our unique longitudinal survey of nearly all MHTFs in the US. We will also collect complementary
qualitative data through interviews with medical directors at MHTFs.
The proposed study is both timely and important, as state policymakers are considering actions to
revise their telehealth policies. The study findings will help them identify policies that have (or haven’t) been
successful in expanding telehealth services for children with mental disorders—especially those who live in
MHPSAs—to inform subsequent policy decisions.

Public health relevance
PROJECT NARRATIVE A national emergency in child mental health has been declared by multiple specialty organizations during the COVID-19 pandemic. While telehealth services have increased rapidly across the nation as promoted by government policy changes during the pandemic, no study to date has examined the extent to which state telehealth policy changes help address the national emergency and reduce disparities in child mental health care between mental health professional shortage areas and non-shortage areas. This proposed study aims to fill the gap through longitudinal analyses of comprehensive primary and secondary data.